Administrative Core

CORE A PROJECT SUMMARY
The Administrative Core (Core A) has two major functions: to provide an effective venue for efficient
coordination of the projects and the scientific core to ensure the success of this PPG, and to provide
administrative support to the Program Director and all three projects and the scientific core in this PPG to
ensure effective and open communication, fiscal soundness, and regulatory compliance. Core A is a conduit
for communication and coordination of this PPG with internal and external advisory boards and other stake-
holders. The Administrative Core will be led by the Program Director who will be assisted by Core A staff
including an experienced Program Coordinator. The Executive Committee, which comprises project and core
leaders and essential co-investigators, is the primary vehicle that the Program Director / Administrative Core
Leader uses to direct and manage this PPG.